Prenatal Exposure to Air Pollution and Childhood Social Anxiety Symptoms: Novel pathogenic pathways

ABSTRACT. Childhood social anxiety is highly prevalent and impairing; in severe cases it can lead to school
refusal and social isolation and is often comorbid with other mental and physical health problems posing a
significant public health burden. Although exposure to environmental toxicants have not commonly been
thought of as contributors to mental health problems, epidemiologic studies have linked prenatal exposure to
ambient air pollution with increased risk for anxiety symptoms and disorders. Children living in the context of
economic disadvantage are at disproportionately higher risk for anxiety and exposure to air pollution. This
proposal integrates findings from environmental health sciences and developmental psychology/neuroscience
and proposes a novel framework detailing the pathway through which prenatal exposure to air pollution
contributes to social anxiety symptoms (SAS) in children who are most at risk. In animal models, prenatal
exposure to polycyclic aromatic hydrocarbons (PAH) – a common class of neurotoxic air pollutants – causes
increased avoidance behaviors, analogous to human behavioral inhibition (BI), a well-documented risk factor
for SAS. Prenatal PAH exposure also alters children’s cognitive control, which in turn increases SAS risk in
children with BI. We have linked prenatal exposure to PAH with BI-like behaviors in infants and children and
with internalizing symptoms and altered cognitive control. We now propose to test the overarching hypothesis
that (1) prenatal PAH exposure is linked with SAS via effects on BI-like behaviors and (2) that prenatal PAH
exposure alters neural function underlying cognitive control, and (3) moderates the association between PAH,
BI, and SAS. We will conduct our study in 200 Black and Latinx children living in the context of economic
disadvantage who are followed in a prospective longitudinal birth cohort at the Columbia Center for Children’s
Environmental Health. Using EEG to measure alterations in brain function associated with PAH exposure will
allow us to show effects of air pollution on children's task-related brain function (versus structure) for the first
time and at very early time points (preschool age) when intervention and prevention may be most effective.
Findings will identify modifiable factors (air pollution) that can be targeted to deliver maximally effective
personalized prevention strategies. Future studies can leverage our findings to develop personalized
prevention strategies targeted to help children from marginalized groups who are at greatest risk for exposure
and poor mental health outcomes.

Public health relevance
NARRATIVE This proposal aims to study pathways that lead to environmentally-associated social anxiety symptoms in Black and Latinx youth living in the context of economic disadvantage, a population that is at high risk for mental health problems but has been underrepresented in neuroimaging research. We propose to investigate effects of prenatal exposure to air pollution on risk for social anxiety symptoms through studying effects of prenatal exposure to air pollution on behavioral inhibition, a marker of social anxiety, and brain function underlying cognitive control, a risk factor for social anxiety in children with behavioral inhibition. The long-term goal is to inform development of novel prevention and interventions programs for social anxiety in youth living in the context of economic disadvantage, and to promote interdisciplinary developmental team science in which the wider mental health system has the skills to work together to improve the health and development of vulnerable children.